Administrative Core

ADMINISTRATIVE CORE
SUMMARY
The mission of the Administrative Core is to support and promote the scientific and outreach goals of the Host
Pathogen Map Initiative (HPMI 2.0). Amongst its responsibilities, the Core will perform the following: provide
leadership that ensures strong oversight and representation of all stakeholders in decisions; facilitate integration
of research projects; and connect the HPMI 2.0 to the broader community interested in infectious disease and
systems biology. Day-to-day activities will be coordinated by a cross-campus team consisting of the HPMI 2.0
Leaders (Dr. Nevan Krogan, the contact PI, and Dr. Jeff Cox) and the co-Investigators (Drs. Zuliani-Alvarez
and Kaake). The leadership team has extensive experience leading and managing large research grants and
will be supported by QBI’s dedicated finance team and the Media and Events team. To facilitate communication
amongst Center members and with the scientific community, the Administrative Core will organize and manage
a number of regularly scheduled meetings. These various meetings will provide ample opportunities to discuss
overall research directions and specific experimental concerns and foster new collaborations. The Core will plan
a workshop for early spring of 2023, which will feature talks by all 15 HPMI 2.0 faculty members along with talks
from other members of the infectious disease community. The Administrative Core, together with the Data
Management and Bioinformatics Core, will lead the maintenance of the HPMI 2.0 website (HPMI.ucsf.edu)
and shared file servers. The QBI Media & Events team will be leading outreach activities, which include the
symposia, seminar series as well as QBI TV episodes focused on infectious diseases, featuring HPMI 2.0 PIs
and invited speakers on the topics. The Administrative Core will further support the trainee exchange between
the Cox lab at UC Berkeley and the Thuong lab in Vietnam. Overall, the Administrative Core will ensure that
projects are productive, synergistic and have sufficient support; that resource-sharing obligations are met; and
that outreach activities are of maximum impact.